Neuroscience of Aging, Neurodegeneration and Alzheimer’s Disease

PROJECT SUMMARY
Population projections made by the US Census Bureau indicate that ~20% of the population will be >65 years
old by 2030, and if correct, this demographic change will have a major impact on the economy and health of
our nation. However, the mechanisms underlying normal and pathological human aging are still poorly
understood, especially those associated with the nervous system, and safe and effective therapies have yet to
be developed. Therefore, the primary aim of this T32 program is to provide students with basic, translational,
and clinical research training in the Neuroscience of Aging and Neurodegeneration. Based on the experience
of our 20-member faculty, who have previous trained 60 pre-doctoral students and 120 postdoctoral fellows,
we expected that a total of 12 PhD or PhD/MD students and 8 postdoctoral fellows will be trained during the
proposed 5-year funding period. Our program is thus expected to make a significant contribution to a national
effort ensuring that there will be a sufficient number of trained researchers available in the ensuing decades,
with expertise in normal and pathological human aging. Importantly, our program does not duplicate any other
training program at OHSU, and it is the only mechanism by which students can obtain comprehensive research
training in the Neuroscience of Aging and Neurodegeneration in the Pacific Northwest.
The T32 training faculty bring ~$20,000,000 in direct research funds to the Oregon Health and Science
University (OHSU) each year, in support of basic, translational, and clinical aging/neurodegeneration research.
Furthermore, the faculty have primary appointments within the Schools of Medicine and Engineering, the
Layton Aging & Alzheimer's Disease Center, the Oregon Institute of Occupational Health Sciences (OIOHS),
the Vollum Institute, the Advanced Imaging Research Center (AIRC), the Jungers Center for Neuroscience
Research, and the Oregon National Primate Research Center (ONPRC). Thus, our program offers training
using a broad spectrum of animal models, including invertebrates, rodents, and nonhuman primates, as well as
humans. It also provides extensive Research Core support and access to a wide range of cutting-edge
resources and methodologies, including advanced in vivo brain imaging at one end of the spectrum and RNA-
seq gene expression profiling at the other. Currently, the program's main aging-related research focus areas
include: perturbed circadian rhythms, neuroendocrine-associated disorders, cognitive decline, movement
disorders, and neurodegenerative diseases such as Alzheimer's and Parkinson's. A special emphasis of our
program is for the trainees to conduct their research projects within a “bench-to-bedside” framework, ensuring
that even our basic science trainees will obtain first-hand exposure to translational or clinical aging research.
The breadth of the training will be further enhanced by requiring all of our trainees to attend a comprehensive
3-term Neuroscience of Aging graduate training course, as well as a monthly Neuroscience of Aging journal
club and a monthly Responsible Conduct in Research class, and participate in OHSU science outreach efforts.

Public health relevance
PROJECT NARRATIVE By 2030, approximately 20% of the US population is expected to be 65 years and older, and so there is an urgent need for better understanding of the physiological changes and mechanisms that underlie normal and pathological aging. This research training grant will provide annual support for 5 predoctoral students and 3 postdoctoral fellows, and will represent an educational cornerstone of the OHSU Healthy Aging Alliance – an organization that involves basic and clinical researchers, health care providers, and also elderly representatives from the local community. The proposed Neuroscience of Aging and Neurodegeneration program will thus provide trainees with a “bench-to-bedside” framework in which to conduct their research, and will better prepare them for future research careers that focus on the development of safe and effective therapies for aging-related neurological disorders.